Genomics Diversity Summer Program (GDSP) at Stanford

Project Summary/Abstract
The Stanford Genomics Diversity Summer Program (GDSP) is designed to help increase the
number of underrepresented scientists pursuing and succeeding in genetics, genomics, or
other research careers. GDSP’s goals are to help participants of diverse backgrounds to: (a)
successfully transition to the next career level; (b) remain in STEM; (c) pursue a PhD relevant
to genomics; and (d) pursue careers in genomics. We support this goal by recruiting highly
qualified students from diverse backgrounds and exposing them to cutting-edge research in
top and well-resourced laboratories. The GDSP introduces and supports students in Genetics
who otherwise may not had such an opportunity, and will serve as a catalyst for the
development of students from diverse and underrepresented communities. Furthermore, this
proposal will enhance the infrastructure of equity and education at Stanford University,
introducing Genetics and Genomics research experiences to underrepresented minority, first
generation college students, female students, students with disabilities, and LGBTQ+ students
who would otherwise lack such opportunities. This will allow them to experience a broad
spectrum of research, and to acquire skills -- such as data analysis used in modern scientific
investigations -- while preparing them for careers in genomics science as well as developing
a vast network of partnerships among scientists from national and international institutions.
Each year, 10-15 diverse undergraduate and post-baccalaureate students will be selected
from across the U.S. as GDSP Scholars. These GDSP Scholars participate in SSRP, a
comprehensive, fully-funded, 9-week summer research program, during which time they work
in genomics laboratories, receiving training in a wide variety of research techniques. The
program prepares diverse participants for applications to PhD towards a PhD program, by
addressing the career, academic, and personal needs of diverse students. With grant support
from the NIH, selected undergraduate students become a part of our Stanford network and
obtain rigorous laboratory experience at a top-tier research institution.
A diverse group of faculty, staff, and students will contribute to the Action Plan, Central to the
success of this plan is a commitment to diversity and inclusion as core values of Stanford.
Building a culture and climate that values diversity and inclusion is the responsibility of all
members of the Stanford community. We acknowledge that diverse people, perspectives, and
backgrounds do not compete with excellence, but instead drive it.

Public health relevance
Project Narrative Research in genetics and genomics affects nearly every aspect for better understanding and treating our public health. The Genomics Diversity Summer Program (GDSP) at Stanford aims to produce a more diverse research workforce that better reflects and understands a growing diverse population while also offering more diverse perspectives in research.